Ecdysoneless, A Novel Regulator of Androgen Receptor

PROJECT SUMMARY/ABSTRACT Prostate Cancer (PCa) is the most frequently diagnosed non-cutaneous cancer in men in the US and the second most common cause of cancer deaths in men. Androgen receptor (AR) is well known driver of PCa, and androgen deprivation therapy is the initial management, but essentially all patients eventually become castration-resistant. Such patients are treated with next generation AR synthesis inhibitors (such as abiraterone) or AR antagonists (such as enzalutamide) but emergence of resistance to these agents eventually limits therapeutic choices. One of the mechanisms for such resistance is defect in AR mRNA splicing. Expression of two splice variants AR-V1, and AR-V7 is 20-fold higher in hormone resistant PCa. The proposed mechanisms include genomic rearrangement of the AR gene or upregulation of specific splicing factors. Two splicing factors, pre-mRNA processing factor 8 (PRPF8) and RNA helicase DDX39B and its paralog DDX39A seem to be involved in export and splicing of AR mRNA. Taken together a large body of evidence suggests a role of AR processing may contribute to more aggressive PCa that is hormone resistant. Therefore, identifying novel mechanisms those regulate AR processing is an important area of research to identify potential future therapy targets in PCa patients. This R21 proposal focuses on a protein ECD, a conserved homolog of the fly Ecdysoneless gene product, which we show is overexpressed in most PCa cell lines, and in Prostatic intraepithelial neoplasia (PIN) and PCa tissues, and its overexpression predicts shorter survival in patients. ECD knockdown in AR+ PCa cells reduced AR mRNA and protein levels, cell proliferation, invasion, migration and anchorage independent growth. Mechanistically, ECD interacts with components of the R2TP co-chaperone complex that plays a key role in the assembly of large protein or protein–RNA complexes. Importantly, the R2TP client complexes are involved in RNA processing. We show ECD binds to PRPF8, and DDX39A and DDX39B, proteins known to regulate mRNA export and splicing. Based on these novel findings, we hypothesize that a ternary complex of ECD, R2TP and mRNA processing proteins (PRPF8 and DDX39) promotes AR export and splicing in PCa to increase cell proliferation, cell survival and oncogenesis. Targeting this pathway can provide a potential PCa therapy strategy. Here, we will first define the composition of the ECD-containing mRNA processing machinery complexes in PCa cells using biochemical and co-localization approaches. Then we will assess the role of ECD in recruiting the mRNA processing machinery to regulate AR mRNA export and splicing in PCa cells. Finally, we will assess the potential of targeting AR mRNA processing by ECD knockdown or by use of CK2 inhibitor with or without enzalutamide. Thus, our studies will establish a new mechanistic paradigm of how PCa hyper-proliferation, cell survival and hormone resistance is driven by a novel mechanism and targeting this pathway synergizes with anti-androgen receptor agents for anti-tumor activity.

Public health relevance
Prostate Cancer (PCa) is the most frequently diagnosed non-cutaneous cancer in men in the US, with 164,690 estimated new cases in 2018, and the second most common cause of cancer deaths in men, with 29,430 estimated deaths in 2018 (www.cancer.org). Given the universal role of androgen receptor (AR) as a driver of PCa, androgen deprivation therapy forms the mainstay of initial management but essentially all patients eventually become resistant to the therapy. Thus, identifying mechanisms that induce therapy resistant prostate cancer is the key to developing newer agents that could be combined with AR-targeted therapies to reduce or overcome resistance. We have identified one such mechanism mediated by a protein called ECD. ECD is overexpressed in PCa patients and its overexpression predicts shorter overall survival in patients. Studies here are geared towards gaining in-depth insights into the workings of this molecular mechanism. A positive outcome of our studies should provide a basis for translating a promising approach into clinic with the prospect of significantly reducing the burden of cancer deaths related to Prostate and other cancers, where ECD is overexpressed.